Core A: Administrative Core

Project Summary – Administrative Core (Core A)
The proposed Specialized Programs of Research Excellence (SPORE) will investigate outcome disparities in
Latino children and adolescents with acute lymphoblastic leukemia (ALL). The Program is built on a multiinstitutional consortium, the REducing Disparities in Acute Leukemia (REDIAL) Consortium, comprising 6
pediatric cancer centers in the southwestern United States, with large proportions of Latino children and
adolescents with ALL. Core A, the Administrative Core, will oversee and coordinate all entities of the SPORE,
which includes four Research Projects (Project 1, therapy-associated hepatotoxicity; Project 2, methotrexate
neurotoxicity; Project 3, pharmacogenomics; and Project 4, patient-reported outcomes, epigenetics, and social
determinants of health [SDoH]); Core B, the Biospecimen Processing and Storage Core; Core C, the Biostatistics
and Data Management Core; Core D, a Community Outreach and Engagement Core; a Developmental
Research Program (DRP); and a Career Enhancement Program (CEP). Collectively, this SPORE will generate
insights into the contributions of ancestry, metabolomics, pharmacogenomics, epigenetics, SDoH, and other risk
factors toward observed population-based disparities in treatment-related toxicities experienced by Latino
children and adolescents with ALL. By facilitating employment, training, regulatory compliance, internal and
external communication, and financial management of the SPORE, Core A will maximize the productivity and
efficiency of all participating components. Under the leadership of Co-Directors Drs. Karen Rabin, Philip Lupo,
and M. Monica Gramatges, Core A will be responsible for overseeing the conduct of the research at the various
sites, including the regulatory, financial, and human resources aspects. Core A will also ensure regular internal
communication among investigators and sites and organize external communication with leaders in the field, the
scientific community, and patient advocacy organizations. Core A will (1) oversee all human resource
management responsibilities, including creation of job descriptions and the hire, evaluation, and replacement of
personnel locally and at the Consortium sites; (2) provide regulatory management and governance, including
tracking regulatory submissions/approvals and assisting with necessary training of research staff; (3) control
expenditures and maintain budget information for all Projects, Cores, and Consortium sites; and (4) facilitate
internal and external communication among all participating Project Leaders, Core Directors, and sites to
ensure adequate enrollment rates, address logistical issues, and present updates on research progress. Internal,
External, and Community Advisory Boards (IAB, EAB, CAB) will be established. Both the IAB and EAB will
include leaders in pediatric leukemia biology, genomics, epidemiology, supportive care, and patient advocacy,
including two leaders of funded SPOREs. The IAB will meet twice yearly, the EAB annually, and the CAB
quarterly. In summary, the Administrative Core will ensure that all aspects of the proposed research program are
conducted in accord with the highest standards of organization, documentation, communication, and fiduciary
responsibility

Public health relevance
Core A: Administrative Core Core A, the Administrative Core, will oversee and coordinate all entities of this U54 SPORE to ensure maximal synergy, productivity, and efficiency of all participating Cores, Projects, the Developmental Research Program, and the Career Enhancement Program. Under the leadership of Co-Directors Drs. Karen Rabin, Philip Lupo, and M. Monica Gramatges, Core A will be responsible for overseeing the conduct of the research at the various sites, including regulatory, financial, human resources, and internal and external communication. The Administrative Core will ensure that all aspects of the proposed research program are conducted in accord with the highest standards of organization, documentation, communication, and fiduciary responsibility.